Early Development in Agenesis of the Corpus Callosum

Project Summary
Neurodevelopmental disorders are abnormalities of brain function and structure resulting from pathologies
affecting brain development during fetal development or early life. They may affect behaviour, learning, and
motor skills, and are associated with an increased risk of epileptic seizures. The incidence of
neurodevelopmental disorders is high in industrialised countries, with around 1 in 6 children affected by
resulting conditions, including cerebral palsy, epilepsy, attention deficit hyperactivity disorder, autism spectrum
disorder, intellectual disability and learning disabilities. Research suggests that the prevalence of certain
neurodevelopmental disorders has been increasing over the last four decades, with significant costs to both
the individual and society. Although earlier identification and intervention leads to improved outcomes for
children with neurodevelopmental disorders, many of these conditions cannot be diagnosed until behavioral
symptoms appear, thereby limiting opportunities to study early development and early interventions. To
overcome this barrier, we are proposing to study infants with agenesis of the corpus callosum (AgCC)
diagnosed prior to 6 months of age.
The overarching aim of this application is to characterize the developmental trajectory of behavior during the
first 3 years of life in children with AgCC, using this information to identify phenotypic factors associated with
increased risk of developmental delays, autism spectrum disorder (ASD), and/or familial distress. 1 in 2000
children is diagnosed with AgCC by 12 months of age, and many of these children receive the diagnosis in
utero. AgCC is defined only by neuroanatomy, but about 30% of individuals with AgCC will develop social
cognitive deficits consistent with ASD. Because AgCC can be diagnosed before birth, it presents a unique
opportunity to learn about early development of social cognitive deficits observed in ASD and related
conditions, and the relationship of these developing behaviors to early organization of the corpus callosum.
Insights regarding increased risk or protection conferred by early neural and behavioral development in AgCC
may inform etiological models of impairment and potentially improve prognostic predictions and treatment
options for children at risk for social cognitive deficits including ASD. In addition to their potential contributions
to research and treatment of ASD and other forms of social impairment, the studies in this application offer
significant public health benefit specific to a heretofore understudied population, children with AgCC and their
families.
Currently, no published research describes early behavioral development in a large cohort of children with
AgCC, despite the fact that it could provide critical information to parents who are determining the future of
their unborn fetus with AgCC or determining how to support the development of a child with AgCC. Cohort
studies of adults with AgCC reveal a broad range of cognitive and adaptive functioning. These variations
appear to be substantially informed by the presence or absence or other neurological abnormalities, but may
also be influenced by developmental factors. However, in the absence of research on early behavioral
development in children with AgCC, it is not possible to identify risk factors or potential interventions relevant to
AgCC, leaving parents with the psychological stress of having a neurologically disabled child whose
developmental trajectory is unpredictable. The proposed research will provide practical information for
clinicians and parents regarding phenotypic variations in AgCC and suggest areas for potential intervention, as
well as novel scientific insights regarding callosal involvement in development of social cognitive deficits.

Public health relevance
Narrative Information on early behavioral trajectories in neurodevelopmental disorders is limited by age of diagnosis, so we are proposing the first study of early development in agenesis of the corpus callosum (AgCC), a neurodevelopmental disorder that can be diagnosed prenatally. We will acquire parent reports at 5 age-based time-points from 6 to 36 months, and direct behavioral assessments in subsample of toddlers with AgCC between 24 and 30 months of age. Leveraging three existing RO1/U01s, we will compare development of children with AgCC to infants/toddlers at high-familial risk (HR) for developing autism (from the Autism Center of Excellence Infant Brain Imaging Study (IBIS)) and a large sample of low-risk comparison children (from Co-PI Elison's BRAINS RO1 and the Baby Connectome U01). This will provide the most detailed understanding yet of early development in AgCC, and inform empirically- based clinical recommendations for this population.